Improving Healthcare Quality and Equity For Older Adults with HIV Under Value-Based Care Models

Project Summary
Life expectancy for people living with HIV (PWH) has increased substantially in the antiretroviral therapy (ART)
era. Consequently, the Medicare program is anticipating a “silver tsunami” of PWH aging into program. There
are substantial concerns about how HIV will affect treatment decisions, quality of care, and clinical outcomes of
older PWH with age-associated multimorbidity, like Alzheimer’s disease and related dementias (ADRD),
cardiovascular disease (CVD), and mental illness. Despite these concerns, we currently lack a national,
comprehensive understanding of how quality and outcomes have changed for PWH over time, or the key
patient, drug plan, market, community, and policy factors that influence care. Quality of care concerns are
especially salient among historically marginalized populations that experience worse care quality at baseline,
including racial and ethnic minorities, rural populations, and low-income adults dual-eligible for Medicaid and
Medicare. A national strategy aimed at improving quality for older adults in the Medicare program is expansion
of alternative payment models (APMs), including Accountable Care Organizations (ACOs), in which a group of
healthcare providers take responsibility for assigned patients’ total costs and quality of care, and Bundled
Payment Models (BPMs), which encourage cost reductions following admissions for specific clinical episodes.
Although APMs have achieved modest savings and improvements in quality for Medicare beneficiaries
generally, there is no empirical data evaluating whether APMs are effective for PWH. There are concerns that
the quality and cost benchmarks in these models may lead clinicians in APMs to avoid high-risk patients like
PWH, or when serving PWH, to limit necessary care due to aggressive cost-containment efforts. As the federal
government expands APMs, it is critical that we understand the impact of APMs on the health of PWH. In this
study, we will use national, longitudinal data (2005 to 2025) to pursue three aims. Aim 1 will evaluate changes
in the quality of care and health outcomes among PWH compared to a matched population without HIV, and it
will also identify the patient-, plan-, market-, clinician specialty-, and community-level factors associated with
better quality, equity, and improved outcomes. Aim 2 will use a quasi-experimental study design to determine
the impact of Medicare ACOs, the largest Medicare APM, on the quality of care and health outcomes of PWH.
Finally, Aim 3 will determine whether Medicare BPMs, the second largest APM, improve or worsen quality and
outcomes for PWH. Findings from this study will offer a national perspective on the key factors, including the
Part D Drug Benefit design, on quality of care and health outcomes of PWH following age-eligibility for
Medicare. We also propose the first national study to evaluate the impact of APMs on PWH. Our work will
inform national clinical, public health and policy efforts aimed at improving quality and health outcomes of PWH
in the Medicare program, including consideration of specific policy modifications for PWH under APMs.

Public health relevance
Project Narrative The proposed project aims to evaluate changes in treatment (e.g., national guideline-recommended antiretroviral therapy), quality of care, and health outcomes (e.g., healthy days at home, mortality) among an increasingly older population living with HIV (PWH) in the Medicare program. Importantly, the proposed research will also identify the patient-, drug plan-, market-, and community-level factors associated with higher quality of care and improved clinical outcomes among a national, longitudinal cohort of older PWH with age- associated comorbidities (e.g., Alzheimer’s disease and related dementias (ADRD), cardiovascular disease, and mental illness) and of historically marginalized subpopulations with HIV. Finally, this work will be the first national study to evaluate the impact of Medicare value-based alternative payment models (APMs) on older PWH, including Accountable Care Organizations and Bundled Payment Models, which can help inform national public health and policy efforts aimed at improving care for PWH, including consideration of specific policy modifications and carve-outs for PWH under APMs.